Ethical Problems of Registered Nurses and Social Workers

During intravascular hemolysis in human disease, vasomotor tone and organ perfusion may be impaired by the increased reactivity of cell-free plasma hemoglobin with nitric oxide (NO). We experimentally produced acute intravascular hemolysis in a canine model in order to test the hypothesis that low levels of decompartmentalized or cell-free plasma hemoglobin will severely reduce NO bioavailability and produce vasomotor instability. Importantly, in this model the total intravascular hemoglobin level is unchanged, only the compartmentalization of hemoglobin within the erythrocyte membrane is disrupted. Using a full factorial design, we demonstrate that free water-induced intravascular hemolysis produces dose dependent systemic vasoconstriction and impairs renal function. We find that these physiologic changes are secondary to the stoichiometric oxidation of endogenous NO by cell free plasma oxyhemoglobin. In this model, 80 ppm of inhaled NO gas oxidized 85-90% of plasma oxyhemoglobin to methemoglobin, thereby inhibiting endogenous NO scavenging by cell-free hemoglobin. As a result, the vasoconstriction caused by acute hemolysis was attenuated and the responsiveness to systemically infused NO donors was restored. These observations confirm that the acute toxicity of intravascular hemolysis occurs secondary to the accelerated dioxygenation reaction of plasma oxyhemoglobin with endothelium-derived NO to form bioinactive nitrate. These biochemical and physiological studies demonstrate a major role for the intact erythrocyte in NO homeostasis and provide mechanistic support for the existence of a human syndrome of hemolysis-associated nitric oxide dysregulation, which may contribute to the vasculopathy of hereditary, acquired and iatrogenic hemolytic states. [unreadable]